Spermatogonial stem cell regulation and maintenance of male fertility

Project Summary
Infertility affects 15% of couples and in about half of these cases the male partner contributes to the failure to
conceive. One cause of male infertility is an inability to produce adequate amounts of sperm. Continuous an
robust sperm production is dependent on the spermatogonial stem cells (SSCs), which have the capacity to
divide to produce more SSCs as well as produce cells that differentiate into sperm. The regulation of SSC
proliferation and differentiation is controlled by a complex regulatory environment called the stem cell niche,
which is comprised of several testicular cell types including, Sertoli, Leydig, myoid, and macrophages.
Furthermore, SSCs are positioned near the vasculature suggesting that circulating factors also contribute to
the SSC niche. How this complex niche manages the SSCs and how the SSCs incorporate the multitude of
signals provided by the niche is not understood. To investigate regulatory mechanisms governing SSC
maintenance, this study utilizes the genetic and experimental attributes of the zebrafish model. This study is
aimed at understanding two processes found to be important for SSCs. Aim1 will investigate SSC maintenance
by post-transcriptional RNA regulation. Our preliminary work identified the Adad1 RNA binding protein as
essential for either SSC establishment or maintenance. We will test the hypothesis that RNA regulation by the
Adad1 RNA binding protein is critical for SSC regulation and sperm production. First, to understand how RNA
regulation controls SSC function, the basic processes regulated by Adad1 in SSCs will be defined:
proliferation, differentiation, quiescence, or apoptosis. Next, to discover mechanisms subject to post-
transcriptional RNA regulation in SSCs, we will identify Adad1 target RNAs and ask how stability of target
RNAs is affected by Adad1. Aim2 will investigate how a moderate tissue stressor, high sperm demand from
frequent breeding, promotes SSC activation and robust sperm production. Our previous work demonstrated
that the Cdk21 cell-cycle regulator is necessary to maintain the germline in breeding males but not in non-
breeding males. We hypothesize that the SSCs respond to moderate stressors, such as high sperm demand,
by invoking a proliferative response. Furthermore, we propose that Cdk21 participates in this process through
activation of the quiescent stem cell (QSC) population. We will test if the wild-type testis invokes a proliferative
response to frequent breeding and if this response involves SSCs. Furthermore, we will test if cdk21 is
required for this proliferative response and specifically if it regulates exit from quiescence in QSCs. The
proposed experiments will reveal insights as to how RNA-based regulation promotes continued fertility through
SSC regulation. In addition, this work may reveal a tissue-wide response to high sperm demand for
maintenance of testis homeostasis and robust fertility. Knowledge gained from this study can be applied to a
better understanding of human reproductive health and to improved methods for diagnosis and treatment of
infertility, assisted reproductive technologies, and development of male-targeted family planning methods.

Public health relevance
Project Narrative Infertility affects 15% of couples world-wide, and millions of couples in the US seek assisted reproductive technology treatments to treat infertility. This study is aimed at elucidating biological mechanisms required for maintaining the testicular germ line stem cell population and thus continuous and robust sperm production. The results of this project will provide novel insights as to molecular mechanisms underlying germ line stem cell maintenance in the testis that can be applied to improved germ cell culture methods, treatments for recovery of testicular function after damage, development of male targeted family planning methods, and improved and more informed assisted reproductive technology treatments.